Phase Ib/II study of safety and efficacy of EZH2 inhibitor, tulmimetostat, and PD-1 blockade for treatment of advanced non-small cell lung cancer

Background: Checkpoint blockade immunotherapy has become an essential therapeutic armamentarium for
treating patients with advanced lung cancer. However, it is an unmet clinical need to improve the therapeutic
outcome, given the fact that only a subset of patients are benefitting from immunotherapy. As we understand
more about the mechanisms of response and resistance, numerous clinical trials are now underway to test
combination therapy to improve the responses. EZH2, an enzymatic component of Polycomb Repressive
Complex (PRC) 2 emerged as a viable target for patients with lung cancer based on the studies showing poor
prognosis with its overexpression and improved tumor control in the mouse models in combination therapy,
particularly with checkpoint blockade immunotherapy. In addition, a first oral EZH2 inhibitor, tazemetostat, was
approved by FDA in early 2020 for patients with advanced epithelioid sarcoma. Therefore, we propose to test
the combination treatment with tazemetostat and pembrolizumab for Veteran patients with advanced non-small
cell lung cancer (NSCLC).
Hypothesis: EZH2 inhibitor, tazemetostat, is able to re-sensitize cancer cells responding to checkpoint
blockade immunotherapy.
Objectives: Primary objectives: Safety and efficacy of the tazemtostat and pembrolizumab combination
treatment for patients with advanced NSCLC who progressed from the front or 2nd line of therapy measured by
Objective Response Rate assessed by RECIST v1.1. Secondary objectives: Disease control rate, progression
free survival, one-year survival rate and duration of response.
Specific aims: Aim 1. Perform an open label single arm phase Ib/II study of safety and efficacy of the EZH2
inhibitor, tazemetostat, and PD-1 blockade, pembrolizumab, for treatment of patients with advanced NSCLC.
Aim 2. Perform exploratory analyses to identify correlative clinical or molecular markers (biomarkers) of
response and resistance to this combination therapy.
Study design: Aim 1. Utilize 3+3 standard dose escalation strategy to determine recommended phase II dose
with 3 dose levels, 400, 600 and 800 mg twice daily of tazemetostat combined with flat dose, 200 mg of
intravenous pembrolizumab. For phase II, we are aiming to enroll a total of 54 patients using Simon Optimum
Two Stage design to test the efficacy.
Aim 2. Biomarker and correlative studies. Primary biomarkers to be tested, H3K27me3 and PD-L1 using tumor
biopsies. Tumor mutational burden, neoantigen and cell free DNA (ctDNA) dynamics will be tested using tumor
biopsies and serial blood draw along with immune monitoring (immunophenotype via flow/CyTOF, NanoString
and multiplex immunofluorescence).
Relevant to Military health: Improving treatment of many types of advanced cancers is critically important to
the health of Veterans. Many Veterans suffer from significant morbidity when they are diagnosed with cancer
that limits their therapeutic options. Immunotherapy is generally well tolerated and has a significant potential for
durable response, however, the benefit is limited to a subset of patients (and Veterans). Therefore, it is
imperative to improve therapeutic efficacy of immunotherapy using rational combinatorial strategies. Emerging
evidence indicates the important role of EZH2 in lung cancer biology and therapeutic resistance. Moreover, the
first oral EZH2 inhibitor is available in clinics. Hence, the proposed trial has a great potential to develop
effective treatment with manageable side effects for Veteran patients with advanced lung cancer who
progressed from the first or 2nd line of therapy.

Public health relevance
Checkpoint blockade immunotherapy has become part of a standard of care for patients with advanced non- small cell lung cancer (NSCLC) and other cancers over the past 5-6 years. It is one of the major breakthroughs in cancer therapeutics given the unprecedented durable responses. However, it is a clinically unmet need to improve the outcome of immunotherapy since only a subset of patients are benefitting. The current proposal is designed to test the combination treatment with the first oral EZH2 inhibitor, tazemetostat and PD-1 blockade for Veteran patients with advanced NSCLC to overcome primary or acquired resistance to immunotherapy. We will determine the recommended phase 2 dose (RP2D) of tazemetostat during phase Ib portion of the study using standard 3+3 dose escalation strategy using 3 dose levels (400, 600 and 800 mg twice daily). For phase II, we will utilize Simon Optimum Two Stage design to evaluate the efficacy at an early time-point to determine futility of the study and estimated 54 subjects will be enrolled.